ARTFL LEFFTDS Longitudinal Frontotemporal Lobar Degeneration, Cycle 2 (ALLFTD2)

ABSTRACT – ALLFTD2: OVERALL SECTION
Frontotemporal lobar degeneration (FTLD) is an overarching term for a group of neurodegenerative disorders
associated with the accumulation of toxic protein aggregates in the CNS, most commonly comprised of one of
two major proteins—microtubule associated protein tau (i.e., FTLD-tau) and TAR DNA binding protein molecular
weight 43 (i.e., FTLD-TDP). FTLD is approximately as common as Alzheimer’s disease in those who manifest
symptoms prior to age 65. FTLD is uniformly fatal, and there are no effective therapies that can slow or halt
disease progression. Approximately 30% of all FTLD patients have a dominantly inherited familial disorder (f-
FTLD), with the three most commonly mutated genes being microtubule associated protein tau (MAPT),
progranulin (GRN), and chromosome 9 open reading frame 72 (C9orf72). Most new therapies will target one of
these gene products. While there are no current clinical or biomarker findings that confidently predict the
underlying proteinopathy in those with s-FTLD, it is likely that some of these agents might also be useful in
sporadic (s-) FTLD, particularly if FTLD-tau and/or FTLD-TDP specific biomarkers are developed. Over the prior
two grant cycles, the Advancing Research and Treatment in Frontotemporal Lobar Degeneration (ARTFL; U54
NS092089) and Longitudinal Evaluation of Familial Frontotemporal Dementia Subjects (LEFFTDS; U01
AG045390) projects (abbreviated ARTFL/LEFFTDS; 2014-2019), and the current ARTFL LEFFTDS Longitudinal
Frontotemporal Lobar Degeneration (ALLFTD; U19 AG063911, 2019-2025) have been successful in many
regards, but numerous knowledge gaps remain. The current proposal represents our plan to continue and
expand efforts in the renewal grant application: ARTFL LEFFTDS Longitudinal Frontotemporal Lobar
Degeneration, Cycle 2 (ALLFTD2). This program will expand the infrastructure and data collection methods by
enrolling 1450 unique persons over 5 years (610 from f-FTLD kindreds and 840 with s-FTLD). Due to the lack of
deep and frequent phenotypic data on key FTLD participants that is crucial for optimizing clinical trial design, a
subset of participants in the late presymptomatic phase of f-FTLD, and early symptomatic phase of f- and s-
FTLD, will undergo clinical, biofluid and imaging data/sample/scan collection every 3-6 months over a 12-month
time span. The Cores will contribute data and expertise to the Projects, which will focus on
asymptomatic/minimally symptomatic f-FTLD (Project 1) and mildly symptomatic s-FTLD (Project 2). If funded,
the ALLFTD2 program will provide data/samples/scans/tissue to the greater scientific community while
addressing several knowledge gaps relating to FTLD, with the ultimate goal of fostering development of effective
treatments for those with FTLD.

Public health relevance
PROJECT NARRATIVE - ALLFTD2 The ARTFL LEFFTDS Longitudinal Frontotemporal Lobar Degeneration, Cycle 2 (ALLFTD2) protocol represents an expanded and comprehensive program involving eight cores and two projects targeting the key subtypes of Frontotemporal Lobar Degeneration (FTLD). The study includes individuals from families affected by inherited forms of FTLD due to genetic mutations (i.e., familial or f-FTLD) and those who have no apparent family history (i.e., sporadic or s-FTLD). The overall goal of ALLFTD2 is to urgently and more efficiently prepare for treatment trials in FTLD by focusing on several major priorities: 1) expand and maintain a large group of well-characterized s- and f-FTLD patients evaluated at expert FTLD centers, and 2) collect comprehensive cognitive, behavioral, and motor data, in addition to imaging, blood, and cerebrospinal fluid to: a) identify the best clinical and biological measures to use for tracking disease in clinical trials, b) identify clinical and biological measurements indicating that a person at high risk of FTLD due to a genetic mutation will begin to have symptoms in a predictable manner, and c) share clinical data, images and biological samples from participants affected by FTLD with the scientific community to address additional scientific questions about FTLD.